Predictors of sleep-dependent Memory Consolidation in Obstructive Sleep Apnea

Dr. Ina Djonlagic is a board-certified neurologist and sleep specialist. She is an associate physician at Brigham and Women's Hospital and an Instructor in Medicine at Harvard Medical School. Her long-term goal is to develop a productive academic career as an independent investigator conducting research in the field of sleep- dependent plasticity in patient populations. This proposal describes a 5-year career development award to foster Dr. Djonlagic's scientific development including knowledge and skills in clinical research methodologies, pulmonary physiology, quantitative EEG analysis and genetics so that the award will ultimately lead to a successful RO1 preparation. The proposed career development plan incorporates the collaboration with the mentors and a network of experienced scientific and clinical researchers designed to provide an intense, closely mentored, patient-oriented research experience in association with a comprehensively structured didactic curriculum to enhance her knowledge in the area of biostatistics and research methods. Dr. Djonlagic's mentors for the award are Dr. Atul Malhotra, Associate Professor of Medicine at Harvard Medical School and Medical Director of the Sleep Disorders Research Program at Brigham and Women's Hospital as well as Dr. Robert Stickgold, an Associate Professor of Psychiatry at Harvard Medical School and Director of the Center for Sleep and Cognition at Beth Israel Deaconess Medical Center. Dr. Malhotra is trained in pulmonary, critical care, and sleep medicine, and is internationally known for his research in sleep- related respiratory physiology. He has considerable support from the National Heart, Lung, and Blood Institute, and an Established Investigator Award from the American Heart Association. He recently received a K24 mentoring award from the NIH to help protect his time solely for the purpose of developing young trainees. He is a mentor on the T32 training grant of the Sleep Division at HMS, and has published over 90 original articles related to sleep apnea. Dr. Stickgold is a leading researcher in the field of sleep, learning and memory. He is also a is a mentor on the T32 training grant of the Sleep Division at HMS and has published numerous articles in preeminent journals such as Science, Nature and Nature Neuroscience on these topics. Both have a well- established record of successfully mentoring and training post-doctoral fellows (M.D.s and Ph.D.s), clinical research fellows, postdoctoral fellows, graduate students and undergraduate students for careers in clinical research. Both laboratories are part of a rich network of dynamic research scientists and are under the umbrella of the Division of Sleep Medicine at Harvard Medical School, which with its affiliated institutions currently has over 70 faculty members and promotes outstanding opportunities for training and personal development. This research proposal builds on previous work and preliminary data Dr. Djonlagic has compiled while working with Drs. Stickgold and Malhotra. Dr. Malhotra and Dr. Stickgold are close colleagues as over 5 years. Their offices are within 30 feet of one another, which enables them to interact regularly to discuss research projects and science. The goal of the proposed research is to test the hypothesis that the pathophysiological mechanisms of OSA (as determined by changes in sleep parameters, number of arousals, measures of hypoxemia, assessment of EEG power spectrum), lead to deterioration in sleep-dependent memory consolidation across memory systems, with the genetic marker APO54 as a modulator. In addition the effects of CPAP in reversing some or all of the measured cognitive deficits will be assessed. Daytime effects of OSA on cognition have often been attributed to other factors such as personality, psychiatric disorders, and general learning disability or in elderly populations to the effects of aging given the overlap in cognitive impairment related to OSA with common neurocognitive disorders. This diagnostic uncertainty can lead to a delay in disease recognition and treatment. Having a better understanding of the impact of OSA on cognitive function is therefore important for healthcare providers in order to improve diagnostic sensitivity and specificity, and to provide appropriate and timely treatment. Ultimately, this research has the opportunity to provide critical information that may in due course alter how sleep apnea is defined and thus provide a major impact on the care of sleep apnea patients.

Public health relevance
Project Narrative Project Narrative Daytime effects of OSA on cognition have often been attributed to other factors such as personality, psychiatric disorders, and general learning disability or in elderly populations to the effects of aging given the overlap in cognitive impairment related to OSA with common neurocognitive disorders. This diagnostic uncertainty can lead to a delay in disease recognition and treatment. Having a better understanding of the impact of OSA on cognitive function is therefore important for healthcare providers in order to improve diagnostic sensitivity and specificity, and to provide appropriate and timely treatment. Ultimately, this research has the opportunity to provide critical information that may in due course alter how sleep apnea is defined and thus provide a major impact on the care of sleep apnea patients. __SpecificAimsTextDelimiter__ Over the last few decades, advances in cognitive neuroscience have expanded our understanding of the functional and neural composition of memory systems, as well as their plasticity and how these systems can evolve over time. A growing literature supports a role for sleep after training in long-term memory consolidation and enhancement. Consequently, interrupted sleep can result in cognitive deficits. Obstructive sleep apnea (OSA) is a common sleep disorder leading to sleep fragmentation and intermittent hypoxia. Previous research has demonstrated the various levels of cognitive deficits in patients with sleep apnea, which extend beyond those primarily associated with sleepiness. Substantial prior literature has been informative, but has also raised interesting questions regarding the distinction between deficits in memory encoding and memory consolidation, and within memory consolidation, the distinction between that which is state-independent and that which is sleep-dependent. To date, there is still no clear understanding of which offline memory processes during sleep are affected by OSA, and few attempts have been made to reveal the mechanistic pathways leading to memory deficits. First, it remains unclear to what extent hypoxia and sleep fragmentation affect sleep homeostasis, and how these variables impact sleep-dependent memory processes. At present, many authorities (Medicare, AASM recommended criteria) have suggested that arousals from sleep be virtually ignored in determining the apnea-hypopnea index in favor of emphasizing hypoxemia. Second, treatment with nightly use of continuous positive airway pressure (CPAP) is effective for medical and cognitive sequelae of OSA. However, given the lack of clarity regarding the specific aspects of memory affected by OSA, it remains unclear to what extent CPAP can reverse OSA consequences on sleep-dependent memory consolidation. Finally, in some OSA patients, genetic determinants of individual susceptibility may also contribute to their “cognitive reserve”, defined as protective factors that determine an individual’s relative ability to compensate for pathologic insults to the brain. Previous research on OSA patients who are APOe4 carriers shows a higher prevalence of cognitive dysfunction. This finding suggests that this allele may increase neuronal vulnerability to oxidative stress and/or sleep fragmentation during respiratory events. The overarching goal of the research proposed here is to test the hypothesis (i) that the pathophysiological mechanisms of OSA lead to deterioration in sleep-dependent memory consolidation across memory systems, with the genetic marker APOe4 as a modulator, and (ii) that CPAP can reverse some or all of these measured memory deficits. In addition, we will explore which aspects of OSA (e.g., changes in sleep architecture, measures of hypoxemia, or the EEG power spectrum) most likely impact sleep-dependent memory processing. To this end, we will use specific cognitive tasks for which sleep-dependent memory consolidation processes have previously been demonstrated by our group and others. In addition, we will carry out quantitative EEG power spectral analyses, to delineate abnormal functioning of brain regions with more precision. Specific Aim #1: case-control analysis ¿ To assess sleep-dependent memory consolidation for procedural memory (i.e., skill memories, such as how to ride a bicycle) and declarative memory (i.e., memory for personal events and general facts) in untreated OSA patients and healthy controls learning benefits on both simple and complex procedural memory tasks compared with healthy controls. Hypothesis #1b: OSA patients will show practice-related learning, but lack off-line sleep-dependent learning benefits on declarative memory tasks compared with healthy controls. Specific aim #2: cross-sectional analysis ¿ To compare sleep-dependent memory consolidation for procedural memory and declarative memory for OSA patients in the untreated condition and after 3 months of CPAP. Hypothesis #2: Use of CPAP will lead to increased overnight improvement on both, procedural and declarative memory tasks. Specific aim #3: mechanistic analysis ¿ To analyze the role of EEG spectral components, hypoxemia and arousals during sleep in predicting deficits in sleep-dependent memory consolidation Hypothesis #3a: Sleep fragmentation will predict more strongly the deficits in sleep-dependent memory consolidation than hypoxemia. Since many major groups (Medicare, AASM recommended criteria) have recommended apneas and hypopneas be judged based on hypoxemia rather than arousals, this outcome would provide critical information that may ultimately lead to a reassessment of how sleep apnea should be defined. Hypothesis #3b: Changes in EEG spectral power, particularly reductions in slow frequencies will predict deficits in sleep-dependent memory improvement. Specific aim #4: genetic analysis ¿ To assess the role of APOe4 allele on sleep-dependent memory consolidation Hypothesis # 4: APOe4 carriers will show more deficits in sleep-dependent memory consolidation than non-carriers, independent of other factors (i.e., sleep fragmentation, hypoxemia, and spectral power.